J. NRSA Training Core

J. TRAINING CORE (TL1)
PROJECT SUMMARY/ ABSTRACT
The fundamental goal of the Weill Cornell Clinical and Translational Science Center TL1 Training Core Program
is to equip predoctoral and early postdoctoral trainees from diverse disciplines with the skills necessary to pursue
transformative clinical and translational research before their career paths are established by offering distinct
educational tracks culminating in advanced degrees that allow trainees to make an immediate impact in the clinic
or in industry. The TL1 Training Program has trained highly successful predoctoral medical students, surgical
residents and early graduate students, nurses and fellows recruited from all partner institutions. The TL1 trainees
are fully integrated into CTSC activities and have access to all services provided by CTSC partners. Building on
our successful training program developed over the last 14 years, we will introduce new courses, technologies
and workshops geared towards team-based research, creativity, leadership, innovation, entrepreneurship,
informatics, and precision medicine. The TL1 program offers a panoply of didactic programs available to TL1
Scholars including an Advanced Certificate in Clinical/Translational (C/T) Investigation intended for trainees who
are interested in learning the fundamentals of Clinical and Translational Research; a Master’s Program in Clinical
and Translational Investigation, the foundation of which is a Mentored Research Capstone Project in C/T
research that is conducted in a team environment; an - MD/MS, program, a Summer Fellowship in C/T research;
and innovative seminars, workshops, and courses offered throughout the year. Other groundbreaking training
includes mentored research and externships/mini-sabbaticals with biopharmaceutical companies that will enrich
trainees’ exposure to various career options in clinical and translational research. The diverse, highly skilled TL1
faculty and mentors are expertly trained to offer support for trainees throughout the program in order to help
them pursue successful translational research careers. The CTSC has also established multiple collaborative
resources to recruit and retain underrepresented populations. The enhanced TL1 will leverage the trainees to
more rapidly advance in the field of Clinical and Translational Science. The planned duration of appointments is
two years and, the projected number of trainees is 10 including 5 predoctoral, 5 postdoctoral trainees.